Resolving the Paradox of Hearing Complaints with a Normal Audiogram: Differential Diagnosis and Perceptual Impacts of Cochlear Deafferentation

Approximately 10% of Veterans with hearing complaints have clinically normal audiograms. Unfortunately,
treatment options for these patients are limited and the outcomes are variable, resulting in a lack of consensus
on how to manage these patients. Loss of the cochlear synapses between inner hair cells and afferent auditory
nerve fibers can co-occur with normal hearing thresholds and may account for these perceptual complaints.
However, subclinical outer hair cell (OHC) damage or central auditory deficits, such as those arising from
traumatic brain injury, could lead to similar problems. The variability in treatment outcomes may be due to
the heterogeneous nature of the underlying damage, which cannot be determined using existing clinical
tests. The best treatment approach may depend on the specific type of damage. Although OHC function can be
assessed with otoacoustic emissions (OAEs), current audiological testing cannot differentiate between
peripheral deafferentation and damage to the central auditory system. However, several physiological measures
are sensitive to deafferentation in animal models. These include the auditory brainstem response (ABR), the
envelope following response (EFR), and the middle ear muscle reflex (MEMR). Our published and preliminary
data show that ABR, EFR, and MEMR measurements are reduced in magnitude among young Veterans who
report high levels of noise exposure during their military service compared to non-Veterans with limited noise
exposure, consistent with animal models of noise-induced deafferentation. In addition, our data indicates that
reductions in these measurements are associated with auditory perceptual deficits such as tinnitus and increased
cognitive load (i.e., listening effort) during complex speech perception. The overall objective of this proposal is
to develop a clinical test for deafferentation and determine the perceptual impacts of this condition. Our central
hypothesis is that patients with deafferentation can be identified by comparing their physiological measurements
to those from a normative sample with a low risk of deafferentation and that patients with abnormal
measurements will have auditory perceptual deficits (tinnitus, hyperacusis, and difficulty with complex speech
perception, including increased listening effort). We plan to test our hypothesis by pursuing three specific aims:
1) Identify normative ranges for ABR, EFR, and MEMR measurements, statistically adjusted for sex and OHC
function, that can be used to identify patients likely to have significant cochlear deafferentation; 2) Compare
ABR, EFR, and MEMR measurements in terms of their ability to differentiate between groups with low vs. high
deafferentation risk; and 3) Characterize the relationship between abnormal physiological measurements and
auditory perceptual deficits. This approach is innovative because it 1) allows for identification of deafferentation
in individual patients; 2) incorporates OHC function, through OAE measurements, into the normative ranges; 3)
investigates the best combination of test measures/stimuli for identifying deafferentation, including the use of
new EFR and MEMR measurements; and 4) assesses increased listening effort during complex speech
perception as a possible consequence of deafferentation. The proposed research is significant because there is
currently no clinical test for deafferentation and the perceptual consequences of deafferentation are unclear,
preventing the development of treatment options. This study is expected to result in 1) identification of
physiological test measures and stimulus parameters, with normative ranges, that we can recommend for clinical
assessment of cochlear deafferentation and 2) clarification of the perceptual impacts of deafferentation. Clinical
recommendations for diagnosing deafferentation will have immediate impacts on clinical practice by allowing
audiologists to test for deafferentation. A clinical test for deafferentation in combination with measurement of
OHC function using OAEs will allow for differential diagnosis of peripheral auditory damage. Future research can
then focus on treatments for specific peripheral sites of lesion (e.g., individualized hearing aid algorithms based
on the degree of OHC damage and deafferentation or drug treatments for synapse repair or regeneration).

Public health relevance
Hearing complaints such as tinnitus (ringing in the ears), hyperacusis (intolerance to loud sounds), and difficulty understanding speech in noisy environments are commonly reported by Veteran patients even when their hearing test is clinically normal. Unfortunately, there is a lack of consensus among clinicians about the best way to manage these patients because treatment options are limited and the outcomes are variable. One of the major barriers to developing treatments for this patient population is that although these patients likely represent a heterogeneous population with etiologies including lesions to the peripheral and central auditory system as well as cognitive deficits, there are currently no test measures that can pinpoint the damage location. This project will enable differential diagnosis of damage to the peripheral auditory system and will characterize the auditory perceptual deficits associated with peripheral damage. This will have a positive impact on Veterans' health because it will allow for the future development of treatments that are specific to the underlying auditory deficit.